Integration of dietary factors and multi-omic signatures of genetic subtypes to understand diabetes heterogeneity

PROJECT SUMMARY/ABSTRACT
Type 2 diabetes (T2D) is a heterogeneous disease that is the result of the interaction between environmental
and genetic factors. T2D heterogeneity has been described with a set of reproducible T2D genetic subtypes
representing the contribution of specific pathways such as insulin resistance and insulin secretion, for T2D risk.
However, the molecular basis of these differences and their potential clinical applicability has not been studied.
Omic technologies allow us to measure metabolic products (metabolomics) and host environment (gut
microbiome) signatures as sources of interindividual variation that can potentially mediate the differences in T2D
risk and may be modified by diet. The overall objective of this project is to identify the metabolomic and gut
microbiome signatures by which these genetic subtypes contribute to heterogeneity in T2D risk and how they
may be affected by diet. I propose to examine 3 Specific Aims: In Aim 1 [K99]: I will define the metabolomic
signatures that correlate and mediate the association between T2D genetic subgroups and T2D risk. For this, I
will leverage data from five multi-ancestry TOPMed cohorts (N=14,306). In Aim 2 [R00], I will define the gut
microbiome signatures that correlate and mediate the association between T2D genetic subgroups and T2D risk
in three multi-ancestry cohorts (N=5,016) from the CHARGE consortium. In Aim 3 [R00], I will determine the
effect modification of diet on omics signatures (metabolomic and gut microbiome) of T2D genetic subtypes in
two settings: observational and after an intervention. For this, I will conduct an interaction analysis to test how
omics signatures of T2D genetic subtypes change by dietary patterns in five multi-ancestry cohorts (N=14,306)
and how these changes correlate with T2D risk. I also will conduct an interaction analysis to identify the
differences between omic signatures of T2D genetic subtypes in response to different diets: nutrient-rich
minimally processed diet, typical American diet, and high-fat low-carb diet. Here, I will leverage data from the
Nutrition for Precision Health trial module 2 (N=1,500), a multi-ancestry, crossover, randomized study. The
successful completion of these aims will yield an integrative model that combines genetic, individual metabolic
variation, and environmental exposures and will identify modifiable targets for tailored dietary interventions in
multi-ancestry populations. The proposed project is within the scope of the NIDDK’s Strategic Plan for Research
Goal 1 (Understanding biological and environmental disease contributors). Together, my expertise, research
plan, synergistic proposed training under the mentorship of interdisciplinary key leaders in mediation analysis
(Dr. Manning) and gut microbiome (Dr. Khalili, Dr. Qi) and metabolism physiology (Dr. Udler/Dr.Shah) uniquely
position me for the completion of these aims and a successful independent career.

Public health relevance
NARRATIVE This research project aims to identify the metabolomic and gut microbiome signatures by which genetic subtypes contribute to heterogeneity in type 2 diabetes risk and how they may be affected by diet. The proposed research is relevant to public health as it is expected to provide new modifiable therapeutic targets to prevent, delay or treat type 2 diabetes. Thus, the project is relevant to the part of the NIH’s mission that concerns improving our understanding of biological and environmental disease contributors that will help to reduce the burdens of complex human diseases such as type 2 diabetes.